Leveraging technology to identify outcome measures for young children with Down syndrome

PROJECT SUMMARY/ABSTRACT
Children with Down syndrome (DS) experience significant weaknesses in communication and language
development in addition to impairments in intellectual ability. There have been significant advances in both
pharmacological and behavioral interventions for children with DS to support their development. Thus, there is
an urgent need to identify appropriate outcome measures to use with young children with DS. Such measures
have been identified for school-age children, adolescents, and adults with DS. However, reliable, and valid
language outcome measures for younger children (2-5 years) with DS are nonexistent, leaving an impossible
task for researchers and clinicians to effectively evaluate the effects of interventions for young children. This
age range is particularly important, as it is a foundational time for language learning and sets the stage for
success both academically and socially upon school entry. Therefore, to better serve this clinical group, we
must identify a feasible, reliable, and valid set of outcome measures for young children with DS. This study will
evaluate the use of language samples collected remotely by caregivers using digital technology to serve as
outcome measures for young children. The study has three specific aims: 1) determine the feasibility and
reliability of language measures derived from two technologically-supported samples: caregiver-collected video
recordings and the Language ENvironment Analysis System (LENA)-based caregiver-child interactions, 2)
determine the validity of the caregiver-collected video recordings and LENA-based caregiver-child interactions
using current gold-standard approaches, including standardized tests and examiner-child interactions, and 3)
determine the relationships between key variables known to impact language in DS (I.e., intellectual disability
and intelligibility) and the variables derived from the caregiver-child and LENA-based interactions. Data
collection will take place in the participants’ homes and will include two time points (1 month apart). The
caregiver-collected and LENA recordings will take place without an examiner present. At each time point the
study team will complete home visits to complete standardized assessments and an examiner-child language
interaction. This method will allow us to establish the psychometric appropriateness of variables derived from
these language sampling approaches, the stability of these variables over a 1-month period, and how they are
influenced by important child characteristics. The information from this project has direct implications for clinical
trials, including both pharmaceutical and behavioral interventions, research paradigms focused on
understanding language development during the early years of development for children with DS, and clinical
services offered to young children with DS.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it contributes to a program of research focused on significantly improving the communication abilities of children with language impairments, specifically children with Down syndrome. There is a lack of research on outcome measures for young children with Down syndrome. This is a critical issue, given the significant advances in pharmacological and behavioral interventions for individuals with Down syndrome; however, it is impossible to evaluate the effectiveness of these interventions given the lack of information on appropriate outcome measures.